Biostatistics and Bioinformatics Core Facility

Project Summary
There are many challenges to securing significant funding from federal agencies, particularly for junior faculty
members. A major obstacle for translational and pre-clinical researchers is a lack of access to comprehensive
data analysis support. In Phase I of the COBRE Center for Diagnostic and Therapeutic Strategies in Pancreatic
Cancer (CDTSPC), the Biostatistics Core was established to serve as a networking, training, and consulting
resource for junior faculty conducting research on pancreatic cancer, as well as for other scholars on campus
seeking to form collaborative partnerships with data scientists. In the Phase II continuation of this project, the
(newly re-named) Biostatistics and Bioinformatics Core (B2C) will continue to play an integral role in the CDTSPC
by providing high-quality, comprehensive study design and data analysis to all researchers of the CDTSPC and
North Dakota State University. Core personnel will assist CDTSPC investigators with all statistical aspects of
their translational and pre-clinical pancreatic cancer research projects in all stages of the process, increasing the
likelihood of CDTSPC researchers securing federally-funded research grants by ensuring properly designed and
well-powered experiments. Securing major funding is essential for the career advancement of CDTSPC Junior
Investigators and the Core, whose sustainability is realized through the receipt of competitive federal funding.
As the only Biostatistics and Bioinformatics Core specializing in pancreatic cancer research in the region, the
B2C will also provide support for projects involving analysis beyond the traditional statistical techniques of the
bench and clinical research into other emerging areas of “big data” research, including bioinformatics, artificial
intelligence, and machine learning. For Phase II, the B2C Core aims are (1) to proactively assist in the statistical
design and implementation of all types of research, with an emphasis on translational and pre-clinical pancreatic
cancer research and (2) to assist in data analysis and reporting of post-experiment data. The B2C is uniquely
positioned to facilitate interdisciplinary and multi-paradigmatic research. The B2C faculty members have a wide
range of expertise in study design and data analysis methods and extensive experience in collaborating with
researchers in pancreatic cancer and many other areas of research. Using this expertise, B2C staff will assist
COBRE investigators with their projects, leading to advanced knowledge and treatment of pancreatic cancer,
and will meet the crucial need of reliable data analysis support to researchers at NDSU.

Public health relevance
Project Narrative Biostatistics and Bioinformatics Core (B2C) As the only Biostatistics and Bioinformatics Core specializing in pancreatic cancer research in the region, the B2C will continue to play an integral role in the Center for Diagnostic and Therapeutic Strategies in Pancreatic Cancer (CDTSPC) and the greater North Dakota State University (NDSU) community by providing high-quality, comprehensive study design and data analysis support to all CDTSPC and NDSU researchers. A specific emphasis will be placed on providing this support at all stages of the research process to the Junior Investigators' translational and pre-clinical pancreatic cancer research projects, ensuring that all projects are properly designed and well-powered and increasing the likelihood of securing competitive federally funded research grants. In addition, Phase II of this project will expand the B2C services beyond traditional statistical techniques of the bench and clinical research into other emerging "big data" research areas, including bioinformatics and machine learning.